Advancing the Coordinating Center for the Canine Cancer Immunotherapy Network

The primary mission of the coordinating center (CC) at the University of Pennsylvania is to facilitate the
performance of immunotherapy clinical trials in dogs with cancer within the K9CIN (previously known as the Pre-
medical Cancer Immunotherapy Network for Canine Trials (PRECINCT)) and to determine the suitability of dogs
with spontaneous cancer to study immunomodulatory agents and combination therapies to inform human clinical
trials. The CC will achieve these goals by supporting a highly coordinated clinical trials network of participating
U01 sites and will work in consultation with U01 investigators, the network's Steering Committee, representatives
from the Comparative Oncology Program (COP) at NCI and an External Advisory Committee to provide expert
services in project management and research technology, data management, and biostatistical and bioinformatic
support. Specifically, PRECINCT's CC will provide comprehensive project oversight, supervise all project
management and regulatory compliance activities, and coordinate site management for all aspects of trial
projects. Through the CC, U01 investigators will have ready access to research services and standard operating
procedures (SOPs) for clinical and immunological monitoring and collection of data, reagents and biospecimens
that will facilitate the performance of clinical research across the network. Patient accrual will be tracked and
where necessary, cross-site accrual will be coordinated within the network to expedite enrollment. The CC will
assist in designating supplemental funds to U01 awardees to support intra-network collaborative projects
identified by a chosen scientific review panel for funding.
We will continue to build infrastructure and expand the network and associate memberships will be
encouraged to achieve the critical mass necessary to build working groups to advance PRECINCT's mission
and build inter-network collaborations with IOTN, PI-DDN and PACMEN. We will extend PRECINCT's Data
Management System to collect, store and share all clinical and correlative data amongst the U01 sites and with
the COP directors and Steering Committee, through the development of a cloud-based workspace that will
facilitate intra-network collaborative projects and we will perform data quality control and re-formatting required
to enable ready upload to the Integrated Canine Data Commons (ICDC). We will build a specimen and reagent
registry that will facilitate sharing and tracking of resources and serve to ensure their most efficient use within
the network. This together with development of a cloud-based workspace, will foster collaborations between U01
researchers. We will provide biostatistical and bioinformatic support for study design and data analysis
to ensure that clinical trials performed within the network are strategically designed and appropriately powered
to achieve meaningful clinical and laboratory data results in the most expedite way. Together, the activities and
expertise provided by the CC will ensure that reliable and reproducible datasets emerge from these studies
which aim to provide essential insight for future translational application to human patients.

Public health relevance
The primary mission of the coordinating center of the Pre-medical Cancer Immunotherapy Network for Canine Trials (PRECINCT) is to provide infrastructure and oversight to a highly collaborative and interactive network of researchers and clinician scientists working to investigate immunotherapeutic strategies in dogs with cancer, identify correlates of immunological and therapeutic responses and determine the value of dogs with spontaneous cancers in informing human clinical trial design. Leveraging the renowned expertise of the University of Pennsylvania in human and canine immunotherapy trials, PRECINCT's coordinating center will provide expert services in project management and research technology, data management and sharing, and biostatistical and bioinformatics support to U01 awardees and network members. This work will advance discovery, promote collaborative research and accelerate the translation of safe and effective immunotherapies into the human cancer clinics.